Intestinal Anion Exchangers: Function & Regulation

Putative anion transporter 1 (PAT1, SLC26A6), an intestinal epithelial Cl-/HCO3- exchanger, also mediates
oxalate secretion critical for maintaining oxalate homeostasis via governing net intestinal oxalate transport.
Intestinal PAT1 has recently emerged as a novel therapeutic target for nephrolithiasis, a kidney disease linked
to defective oxalate secretion. In fact, Slc26a6-null mice exhibit defective oxalate secretion, hyperoxalemia,
hyperoxaluria and high incidence of kidney stones. Also, patients with kidney stones display mutations in
slc26a6 gene. In view of this critical role of PAT1 in normal physiology and pathophysiology of nephrolithiasis,
an in-depth understanding of the mechanisms of its regulation in health and disease is warranted. There has
been limited progress in understanding regulation of PAT1 due to technical challenges in dissecting its role
from that of SLC26A3 (Down-regulated in Adenoma, DRA, another key intestinal epithelial anion exchanger),
as both proteins are localized to IEC luminal membranes and mediate identical anion exchange activities. We
have now uncovered a novel in vitro model utilizing intestinal epithelial SK-CO15 cell line that shows abundant
expression of PAT1 with negligible DRA expression. Our preliminary data in SK-CO15 cells provide strong
evidence for distinct mechanisms for modulation of PAT1 expression involving transcriptional activation by
CDX1 and HNF4α, posttranscriptional repression by microRNAs, and posttranslational regulation by
autophagy. Further, PAT1 was markedly reduced in response to infection by Cryptosporidium parvum, a
diarrheal parasite that specifically infects the small intestine and is a common opportunistic pathogen in HIV
patients known to be at high risk for nephrolithiasis. Our preliminary data envisage the critical need for detailed
investigations of the regulatory mechanisms of PAT1 expression to unravel its underexplored role in health and
disease. We, therefore, hypothesize that expression of intestinal epithelial PAT1 is regulated at transcriptional,
posttranscriptional and posttranslational levels via novel mechanisms that are also altered in gut infection
causing impaired PAT1 expression and function. Our hypothesis will be tested utilizing SK-CO15 cells,
intestinal organoids, and mouse models. The Specific Aims are: 1. Elucidate
transcriptional/posttranscriptional mechanisms of regulation of PAT1 expression and function in SK-CO15 cells
and mouse enteroids; 2. Determine the role of autophagy in basal or C. parvum-induced modulation of PAT1
expression; 3. Elucidate the mechanisms of regulation of PAT1 expression in vivo in normal mice or in
response to C. parvum infection. Overall, in addition to establishing a novel in vitro model to study PAT1
regulation, our studies should yield critical insights into the molecular mechanisms of intestinal PAT1 regulation
and unravel potentially novel therapeutic targets for diseases associated with impaired intestinal PAT1 function
and expression.

Public health relevance
Narrative Putative anion transporter 1 (PAT1, SLC26A6) mediates intestinal oxalate secretion critical for maintaining oxalate homeostasis. This transporter has recently emerged as a novel therapeutic target for diseases linked to defective oxalate secretion, such as nephorolithiais. An in-depth understanding of the mechanisms of regulation of PAT1 is, therefore, warranted to unravel the key roles of this anion transporter in health and disease. Thus, studies proposed in the current application are designed to provide critical and novel insights into the mechanisms of intestinal PAT1 regulation under normal physiology and in response to gut infection to identify potential novel therapeutic targets for diseases associated with its reduced expression and/or impaired function.